A comprehensive web-based program to help advanced cancer patients plan for end of life

1 PROJECT SUMMARY/ABSTRACT
2 Despite recent advances in cancer care, many cancer patients will ultimately die from their disease as cancer
3 is the second leading cause of death among men and women in the U.S. As such, many cancer patients will
4 ultimately be left to plan for a multitude of end of life care needs. To date, most interventions have focused
5 solely on assisting cancer patients with their advance care planning, neglecting the large number of other tasks
6 patients must complete to get their affairs in order prior to end of life. Most patients report that what matters
7 most to them in preparing for their end of life is not only advance care planning, but also resolving emotional,
8 relational, and spiritual issues; not being a burden to their family, and having their financial affairs in order.
9 Despite the overwhelming number of tasks that patients have to complete prior to their end of life, there are
10 very limited tools or resources to easily guide patients through this process. Our proposed web-based program
11 intervention, which utilizes the Goal-Setting Theory of Motivation as a framework, is designed to guide patients
12 through all of the necessary tasks needed to comprehensively plan for end of life in a easy to follow checklist
13 with assistance and explicit details on how to complete each task. The goals of this study are to: (1) field-test
14 the web-based program intervention among cancer patients using “Think Aloud” exercises, usability testing
15 protocols, and an iterative design approach and (2) evaluate the feasibility, acceptability, usability, satisfaction,
16 user engagement, and preliminary efficacy of the finalized version of the web-based program among cancer
17 patients to improve patients’ levels of engagement in end of life planning (checklist of completed items across
18 the end of life planning domains); patients’ distress and emotional, financial, social, and spiritual well-being. To
19 meet these goals, we will refine the intervention based on stakeholder feedback from n=10 cancer patients and
20 n=10 caregivers to refine the web-based program. Next, we will enroll n=15 advanced cancer patients in an
21 open trial of the intervention to evaluate the feasibility, acceptability, usability, satisfaction, and user
22 engagement of the modified version of the intervention. Finally, we we will randomize n=50 cancer patients to
23 the intervention group and n=50 cancer patients to the control group (usual care) and assess outcomes at
24 baseline and 4 weeks post-intervention to determine the preliminary efficacy of the intervention. Grounded in
25 the Goal-Setting Theory of Motivation, the proposed research takes the novel approach of utilizing digital
26 health platforms (e.g., web-based program) to assist patients in a comprehensive approach to end of life
27 planning. Upon successful completion of the proposed research, we expect our contribution to be a fully
28 developed and tested intervention tailored to cancer patients that demonstrates feasibility, acceptability,
29 satisfaction, and potential efficacy at improving engagement in comprehensive end-of-life care planning.

Public health relevance
PROJECT NARRATIVE The proposed research is consistent with broader public health goals focused on improving patient end-of-life care and patients’ expressed preferences for help with more comprehensive end-of-life care planning that includes advance care planning as well as other end of life issues such as emotional, relational, and financial. The proposed study will address this public health issue by refining and pilot testing a web-based program designed to assist cancer patients in comprehensively planning for their end of life, including advance care planning, estate planning, organizing documents and contacts, and addressing emotional, social, and spiritual needs. Therefore, this study is aligned with patients’ expressed preference for a more comprehensive approach to planning for end of life, as well as the NCI’s long-term goals of improving end of life planning and development of digital health tools, the NINR’s goals of identifying multi-dimensional palliative care needs of older adults and their family caregivers, and the NIA’s objective of incorporating social determinants of health and patient-centered variables.